U-RISE at Cal Poly

The persistent lack of diversity among scientists in the biomedical field is a critical issue affecting our nation’s
health and the future of research. People of color, individuals with disabilities, and socioeconomically
disadvantaged individuals are persistently underrepresented in the research workforce. Intentionally designed,
structured training programs are critical for underrepresented students given evidence of their lower retention
and sense of belonging in science programs, and the perceived disconnect of scientific research from their
personal experience and values. U-RISE at Cal Poly will build on an existing, inclusive infrastructure to
establish a novel, evidence-based training program where students from underrepresented groups engage in
research opportunities, develop their identities as scientists, and leave inspired and well prepared for success
in graduate school in the biomedical field. U-RISE at Cal Poly consists of four key components over a 2-year
training program: 1) Mentoring team and individual development planning; 2) Robust mentored research
experience; 3) Formal coursework to build capacity and support development as a scientist and 4)
Programmatic enrichment events outside the classroom (e.g., research seminars, professional development,
team building). The primary objective of U-RISE at Cal Poly is to provide a comprehensive, mentored, two-year
biomedical research training program that will serve as a pathway for UR students to complete a biomedical,
research-focused graduate degree. Additional objectives to be achieved include (1) improvements in A)
Conceptual and technical skills needed to conduct and disseminate biomedical research in an ethically
responsible and rigorous manner, B) Knowledge of biomedical research careers and professional development
skills to pursue biomedical graduate education, and C) Science identity, self-efficacy, and belonging in
biomedical research; and (2) enhance promotion of diversity, equity, and inclusivity in biomedical research at
Cal Poly in terms of both faculty engagement and students perceptions.

Public health relevance
PROJECT NARRATIVE The persistent lack of diversity among scientists in the biomedical field inhibits our ability to effectively address the complex array of health problems and disparities that affect our nation and the world today. U-RISE at Cal Poly is a training program that incorporates best practices from evidence-based training programs, providing underrepresented undergraduate students the experiences needed to pursue a biomedical, research-focused graduate degree. The multi-faceted program includes mentored research experiences, didactic instruction on conceptual and technical research skills, mentoring teams, and specialized curriculum emphasizing the prosocial value of biomedical research, building identity as a scientist, fostering a deep understanding of health equity, and developing knowledge and skills to direct research towards current health challenges.